DAPSONE FOR PROPHYLAXIS OF PNEUMOCYSTIS CARINII PNEUMONIA IN PEDIATRIC HIV

It is now recommended practice to administer pneumocystis carrinii pneumonia (PCP) prophylaxis to all HIV infected children considered to be at high risk for (PCP). The drug of first choice is trimetroprim- sulfamethoxazole (TMP SMX). The purpose of this study is to compare 2 doses of dapsone for prevention against PCP in HIV infected infants and children who can't tolerate (TMP SMX) . The primary objective of the study are to compare the toxicity of daily versus weekly dapsone for PCP prophylaxis, and to collect study information.